Identifying Diagnostic Markers for Cervical, Breast, and Prostate Cancer

We published our observations on nonalcoholic steatohepatitis (NASH)-induced hepatocellular carcinoma (HCC) and its precursor lesions, nonalcoholic fatty liver disease (NAFLD). To investigate tumor heterogeneity and clonal evolution in this tumor type with increasing incidence, we assessed copy number changes of genes associated with hepatocarcinogenesis and oxidative pathways at a single cell level. Eleven patients with NASH-HCC and 11 patients with NAFLD were included. Eight probes were analyzed using multiplex interphase fluorescence in situ hybridization (miFISH), single-cell imaging and phylogenetic tree modelling: Telomerase reverse transcriptase (TERT), C-Myc (MYC), hepatocyte growth factor receptor tyrosine kinase (MET), tumor protein 53 (TP53), cyclin D1 (CCND1), human epidermal growth factor receptor 2 (HER2), the fragile histidine triad gene (FHIT) and FRA16D oxidoreductase (WWOX). Each NASH-HCC tumor had up to 14 distinct clonal signal patterns indicating multiclonality, which correlated with high tumor grade. Changes frequently observed were TP53 losses, 45%; MYC gains, 36%; WWOX losses, 36%; and HER2 gains, 18%. Whole-genome duplications were frequent (82%) with aberrant tetraploid cells evolving from diploid ancestors. Non-tumorous NAFLD/NASH biopsies did not harbor clonal copy number changes. Fine mapping of NASH-HCC using single-cell multiplex FISH shows that branched tumor evolution involves genome duplication and that multiclonality increases with tumor grade. The loss of oxidoreductase WWOX and HER2 gains could be potentially associated with NASH-induced hepatocellular carcinoma. In addition, four collaborative studies were published this year. Two of these publications delineate the role of HPV integration and extrachromosomal DNA, respectively, on tumor heterogeneity, clonal evolution and tumor aggressiveness. The other two studies report on new therapeutic targets and drugs in renal cell carcinoma.